ACL-LIFE Life History Interview and Validation

To understand the social determinants of health and address persistent disparities in healthy aging,
researchers and policymakers have increasingly taken a life course view of social exposures. Conditions of
early and midlife are implicated in empirical studies of later life health and health disparities by gender, race
and ethnicity, and socioeconomic status. A better understanding of the long-term influences of complex and
time-varying health, socioeconomic, psychosocial and environmental exposures is essential for evaluating
theories of the life course, cumulative advantage and health disparities, and for designing interventions to
foster healthy aging for all. Key methodological advances in the collection of retrospective life history (RLH)
data have enabled major ongoing longitudinal studies of aging, including the English Longitudinal Study of
Ageing (ELSA), the Survey of Health and Ageing in Europe (SHARE), and the Health and Retirement Study
(HRS), to fill in life course gaps quickly and cost-effectively by collecting information using the event history
calendar approach. The data from RLH interviews can be used to generate measures of schooling,
relationship, parenting, employment, financial and residential histories; life events like health shocks; presence
and quality of social network relationships; and behaviors like tobacco use or health care utilization. However,
the reliability of RLH interview data has not been comprehensively evaluated against the survey “gold
standard” of prospectively-collected information. The few assessments of RLH data quality have focused on
different domains of the life course, but each has revealed evidence of recall error (especially by duration since
event and complexity of reporting task) and recall bias (especially by age, gender and sometimes race and
education), though findings remain mixed and incomplete. We propose to build on the existing prospective
Americans' Changing Lives (ACL) study, a multi-racial, nationally-representative cohort study that has
collected measures from across major life domains and of aging-related morbidities over the adult lifespan.
The ACL-6 wave is currently in the field, and will provide 33 years of exposure measures. We will field a RLH
interview similar to the one used by SHARE (ACL-LIFE) and conduct an innovative, integrated set of analyses
to more comprehensively examine the prevalence, dimensions, and sociodemographic determinants of
mismatch between retrospectively- and prospectively-collected life history information than has been possible
to date. We will also explore whether and how reliance on RLH data could influence conclusions about healthy
aging or health disparities drawn from analyses using life course exposures as predictors. These novel
assessments will inform research on survey methodology and enhance the value of major ongoing longitudinal
studies of aging. They will also provide critical findings for researchers and policy makers reliant on cost-
effective and timely information about life course exposures that can be used to improve the lives of all adults,
and to eliminate disparities in healthy aging.

Public health relevance
This project evaluates mismatch in life history data collected retrospectively versus prospectively, using the American's Changing Lives (ACL) Study - a nationally-representative, three-decade panel of adults. The study contributes to two overarching goals of the Public Health Service: increasing healthy active life expectancy and reducing social disparities in health.